Neurobiological Role of MicroRNA in Alzheimer's

Our goal is to identify mechanisms leading to neurodegeneration in Alzheimer's disease (AD). We will study
the regulation of amyloid-β precursor protein (APP), microtubule-associated protein tau (MAPT), −Synuclein
(SNCA), and RE1-Silencing Transcription Factor (REST). This proposal will test miR153 as a 'regulator of the
regulators'. We have established that miR153 regulates the translation of important AD-associated mRNAs for
APP, SNCA, and REST via the untranslated region (UTR). We propose testing the hypothesis that miR153
serves as a nexus regulator of multiple AD-related proteins and control neuronal survival. This proposal will
significantly advance the understanding of miR153's role in regulating proteins related to neurodegeneration.
SA1. Analyze miR153 interacts with target sites in REST-153 network (R-153net) partner mRNAs. The
proteins REST, APP, tau, IL1α, and IL6 play critical roles in AD. A "master regulator" that controls such protein
levels could be a vital tool to prevent AD-related neurotoxicity. We will test the activity of miR153 on multiple
mRNA-fused reporter clones based on the mRNA sequence of selected genes. We expect miR153 treatments
will silence predicted target sites, and miRNA treatment will further alter protein levels in cell cultures.
SA2. Test miR153 perturbs expression of the R-153net and cell health and growth. We will define the
neurobiology of miR153's interactions, including reactive oxidizing species (ROS). We will establish effects on
native protein levels and cell survival. Identifying the roles of miRNA-mediated regulation of the R-153net will
elucidate miRNA-dependent mechanisms to enhance cell vitality. We expect that miR153 interacts with overall
cell health, and these studies will reveal mechanisms for miR153 function in cell survival.
SA3. Measure miR153 treatment alters the R-153net in induced pluripotent stem cells (iPSC). We will
test the effects of miR153 treatment in differentiated iPSC from normal and AD donors. We expect that miR153
will alter R-153net levels and cell vitality and morphology. "Forking" iPSC cultures into neurons, glia, and
mixed-type cell induction will allow for explicitly measuring effects in each of the major brain cell types.
SA4. Assess miR153 is dysregulated in AD stage and brain region-specific manners. We will test and
model miR153, mRNA, and protein levels in AD, MCI, and control human brain samples, along with APOE,
sex, and age vs. disease progression. We expect levels of miR153 and R-153net proteins and mRNAs to vary
in progression-dependent manners. Our results will predict the risk associated with R-153net member levels.
SA5. Identify SNPs near MIR153 genes associate with altered CSF Aβ and phospho-tau levels. We
will identify the effects of SNPs close to the MIR153-1 and -2 genes. We will investigate large-scale genomic
data for SNP associations with AD endophenotypes, which will provide predictive AD biomarkers. Our studies
in cell cultures, iPSCs, miRNA expression in human brains, and identifying SNPs near MIR153 genes
will establish their relationships to AD and lead to novel diagnostic and therapeutic strategies.

Public health relevance
Project Narrative: Alzheimer’s disease (AD) is the most common form of age-related dementia, with no cure; failures of recent clinical trials highlight need for continued research into novel therapeutic targets, such as microRNAs (miRNA), and we propose to study regulation of apoptosis and related proteins, which are co-regulated by a specific microRNA species (miR153) that we have recently discovered to regulate cell survival. Our central hypothesis is that miR153 serves as a nexus regulator of multiple AD-related proteins, and would control neuronal health, and this proposal will significantly advance understanding of biological role of a specific miRNA species, miR153, in AD. Identifying the role of miRNA-mediated regulation of identified gene products, particularly within the REST- miR153 network, should elucidate miRNA-dependent mechanisms, which would lead to novel diagnostic and therapeutic strategies for AD.